Investigating the role of telomere failure on intestinal stem cell niche function

Project Summary
The clinical and biological consequences of telomere dysfunction manifest in telomere biology disorders like
dyskeratosis congenita (DC). DC is an inherited multisystem disorder characterized by degenerative phenotypes
in tissues with high cell turnover, which often includes bone marrow failure and gastrointestinal (GI) disease. GI
pathologies in DC patients include enterocolitis, mucosal ulceration, and malabsorption—findings that indicate a
link between telomere dysfunction, intestinal regeneration, and gut barrier integrity. Thus, we seek to elucidate
how telomere dysfunction impacts the homeostatic turnover of the intestinal epithelium (IE) to inform future
therapeutic approaches. In the IE, intestinal stem cells (ISCs) require canonical Wnt/β-catenin pathway activity
to maintain the tissue’s rapid cell turnover. Our lab discovered that Wnt activity and telomere fidelity lie in a
positive feedback loop—telomerase and telomere capping genes are Wnt pathway targets, and telomere fidelity
is required to sustain Wnt target gene expression. Recently, a population of mesenchymal Foxl1+ telocytes in
the lamina propria directly underlying the IE has been identified as the critical niche source of Wnt ligands
required for ISC proliferative self-renewal. However, in the context of telomere dysfunction, ISCs exhibit a loss
of self-renewal and a broad downregulation of Wnt target gene expression, corresponding to the downregulation
of Wnt ligands now known to secreted from subepithelial telocytes. The goal of this proposal is therefore to
understand the consequences of telomere dysfunction on ISC niche function. Our overarching hypothesis is that
telomere failure suppresses telocyte-derived niche support for ISCs, contributing to the intestinal phenotypes
associated with telomeropathies. To address this hypothesis, we will utilize a novel Foxl1CreERT2-2A-tdTomato reporter
mouse line that will allow for direct in situ visualization of Foxl1+ telocytes, crossed with an mTerc-/- mouse line
that features genetic deletion of the telomerase RNA component (mTerc), leading to loss of telomerase activity
and progressive telomere dysfunction. We seek to determine the niche factor gene expression and telomere
defects in Foxl1+ telocytes in mTerc-/-::Foxl1CreERT2-2A-tdTomato mice by a combination of in situ assays and single-
cell RNAseq on isolated telocytes. We will also determine the functional consequences of telocyte-specific
defects on ISC self-renewal by utilizing primary organotypic co-culture assays in which primary telocytes and
crypt epithelia-derived organoids from mutant mTerc-/-::Foxl1CreERT2-2A-tdTomato and control reporter mice are
isolated and co-cultured. Lastly, we will determine whether wildtype donor bone marrow-derived telocytes have
the ability to engraft within the lamina propria of mTerc-/- mice and rescue ISC function by restoring niche-derived
Wnt activators to the ISC compartment. The findings from this proposal will elucidate how telomere dysfunction
alters the ISC niche, and thus inform future therapeutic approaches aimed toward alleviating telomere
dysfunction-driven disorders like dyskeratosis congenita.

Public health relevance
Project Narrative The intestinal epithelium plays critical roles in digestion and pathogen defense, and its integrity is maintained by a pool of proliferative intestinal stem cells. Recently a population of subepithelial mesenchymal telocytes have been identified as a critical niche population supplying cytokines to support stem cell activity. We address whether telomere dysfunction, which occurs during natural ageing and pathologically in telomeropathies, results in intestinal stem cell failure due to a loss of extrinsic niche support from the telocyte stem cell niche.